MIRHIQL Resource Center for Improving Quality of Life with Chronic Pain (MRC)

Project Summary
Despite acknowledging the challenges of long-term opioid use (LTOT) in clinical and research studies, there is
no consensus on clinically defining opioid misuse. In clinical practice, screening and risk/benefit calculations
remain difficult because while opioid use can be problematic, it may be beneficial in certain subpopulations.
The combination of variables that could be used clinically to assess the risk of harms versus quality of life for
people on LTOT has not been established. It may be possible to decrease some of the tension between
prescribers and patients if clinical providers have a working clinical definition and improved ways of assessing
whether a patient is a candidate for LTOT. The MIRHIQL Resource Center's (MRC) long-term goal is to
understand how chronic pain (CP) and related factors influence the progression of LTOT behaviors. The
objective of MRC center is to create a research community that connects the MIRHIQL network to IMPOWR
research centers and larger HEAL network to translate findings while developing a key opioid misuse and
LTOT infrastructure. We hypothesize that defining opioid misuse and the LTOT benefit/risk framework will
require integrated patient-centered clinical approaches that address the systemic issues affecting healthcare
delivery and the patient-provider interaction, leading to a fundamental shift in how healthcare providers and the
public are educated. These goals will be achieved through the following specific aims: (1) the MRC will
harmonize data collection and common data elements for the MIRHIQL network, providing coordinated support
for network activities while connecting to the IMPOWR Network and larger HEAL Ecosystem via our IMPOWR
CC, (2) The MRC will clinically define opioid misuse with associated risks/benefits using an interconnected
strategy including multi-society expert Delphi, qualitative interviewing of prescribers and people with lived pain
experience, and phenotyping and validating cohort definitions in electronic health and administrative claims
data, and (3) The MRC will perform analytical and clinical validation of screening and benefit/risk tools for
LTOT and definition of opioid misuse in a cohort trial comparing different combinations of relevant OM
variables. Usability (system/provider input) and user experience (provider/patient input) will evaluated for
clinical utility in real-world clinical settings. These aims will provide a coordinated integration of systematic
review, qualitative interviewing, EHR and claims data, and expert Delphi Taskforce to identify and test
candidate variables for a clinical definition of opioid misuse and develop screening and risk/benefit tools for
clinical care. The proposed research is innovative because we will be able to leverage the large-scale claims
(CMS and private payer) and EHR data to build a framework for LTOT care on a rapid timeline. These results
will support future research but will also have direct clinical impact, aligning with NIH HEAL's mission.

Public health relevance
Public health relevance centers on addressing the complex relationship between chronic pain management and opioid medication use, where we lack clear guidelines for identifying appropriate candidates for long-term opioid therapy. This project will refine and validate a clinical definition for opioid misuse through multi-society expert consensus and comprehensive electronic phenotyping, creating standardized frameworks to improve chronic pain care while addressing opioid misuse risks. The research directly supports NIH HEAL Initiative and NIDA's mission by enabling better identification of intervention points across medically underserved populations, ultimately enhancing individualized patient care at the critical intersection of chronic pain and opioid use.